FASEB SRC: The Translational Neuroimmunology Conference: From Bench to Bedside and Back

Project Summary
The purpose of this R13 proposal is to support the attendance of trainees, young investigators, and individuals
historically underrepresented in science and medicine, at the 2022 FASEB Conference: Translational
Neuroimmunology: From Bench to Bedside and Back. This will be the 15th biannual FASEB Neuroimmunology
conference, the first having been held in 1988. The current meeting will be held August 29-September 2, 2022
at the Renaissance Asheville Hotel in Asheville, North Carolina. Neuroimmunology is one of the fastest
growing fields in biomedical research. It has also been one of the most fruitful in terms of the successful
translation of wet bench discoveries into impactful clinical therapies. The overall intent of this conference is to
bring together the world’s leading scientists, young investigators, and trainees, who are engaged in
neuroimmunology research from a broad range of perspectives, in a collegial and supportive environment. The
specific goals are to: 1) provide a forum for the presentation of unpublished, cutting-edge research on immune-
nervous system interactions during health and disease, by speakers from diverse backgrounds; 2) provide
opportunities for both formal and informal discussions on neuroimmune pathways in health and disease, the
environmental and genetic factors that influence those pathways, and efforts to translate scientific insights in
neuroimmunology from “bench to bedside”; 3) support the participation of young investigators, particularly
those traditionally under-represented in the field, and facilitate their integration into the broader research
community in a meaningful and interactive way; (4) promote principles of rigor, transparency, and equipoise in
the conduct and evaluation of research. The program is intentionally multifaceted to ensure that attendees
working on different aspects of Neuroimmunology research have the opportunity to meet colleagues with
complementary interests and areas of expertise, either one-on-one or in small group settings. The agenda
consists of a series of sequential sessions in a single track, without competing talks, and unscheduled
afternoon time to encourage informal communications. These collective features of the conference will facilitate
brainstorming and mentoring in a variety of formats. A priority is to inspire women scientists, and learners and
junior faculty from groups that are traditionally underrepresented in science and medicine, and to connect
those individuals with role models, future mentors, and peers, thereby strengthening their commitment to
Neuroimmunology research. To that end, we are introducing workshops on “How to Forge Collaborations with
Clinicians and Translate Wet Bench Findings to Human Studies”; “Women and Under-represented Minorities in
Neuroimmunology: Challenges and Opportunities”; and “Scientific Rigor and Transparency in Research”, as
well as a career panel discussion on “Career Trajectories in Neuroimmunology”. This conference is designed
to foster creative partnerships and collaborations between wet bench scientists, clinical trialists/ researchers,
and clinicians who are focused on Neuroimmunology, ultimately leading to clinical advances in the field.

Public health relevance
The goal of the 2022 FASEB Conference: Translational Neuroimmunology: From Bench to Bedside and Back is to bring together the world’s leading scientists, young investigators, and trainees, who are engaged in neuroimmunology research from a broad range of perspectives, in a collegial and supportive environment. This conference will highlight cutting edge discoveries about the intersection between the nervous system and the immune system in the context of homeostasis, development, aging, and disease. A major priority is to support the continued advancement of a diverse group of promising young scientists, including women and individuals from underrepresented groups, who will perpetuate the long-term success of the field.